Secondary Prevention of Small Subcortical Strokes

Scientific collaboration between the VA and the NINDS in relation to the Cooperative Studies Program Clinical Research Pharmacy Coordinating Center serving as the drug distribution center for the multi-center trial on Secondary Prevention of Small Subcortical Strokes.